Optical probe and instrumentation development for in vivo near-infrared fluorescence imaging of Alzheimer's disease

PROJECT SUMMARY / ABSTRACT
The main neuropathological hallmarks of Alzheimer's disease (AD) are the extracellular accumulation of amyloid
plaque deposits and intracellular formation of neurofibrillary tangles (NFTs). To enable the study of disease
progression and the effect of therapeutics in preclinical mouse models of AD, there is an urgent need for non-
invasive methods of imaging both hallmarks in the living brain. The most established non-invasive imaging
approaches at the whole animal level are magnetic resonance imaging (MRI), positron emission tomography
(PET), and single photon emission computed tomography (SPECT). However, only optical techniques like near-
infrared (NIR) fluorescence imaging have the theoretical spatial resolution to image individual amyloid plaques
and NFTs. In contrast to PET and SPECT, NIR fluorescence has the additional advantage of using safe, non-
ionizing radiation. Previous NIR fluorescence probes for AD have mostly emitted in the 600-650 nm wavelength
range. While these probes can be used to provide low resolution, bulk estimates of AD pathology burden in vivo
and to distinguish between AD mice and wildtype controls, they lack the ability to provide absolute quantitation
and cannot be used to image non-invasively with microscopic resolution. To enable non-invasive optical imaging
through the intact scalp and intact skull of mice, the wavelength of the fluorescent probe needs to be shifted into
the NIR-II spectrum (1,000-1,700 nm). At these longer wavelengths, the penetration depth through tissue is
increased dramatically while the background caused by intrinsic autofluorescence is minimized. Here we
propose to develop and identify candidate probes for NIR-II imaging by employing two complimentary strategies.
In the first approach, we will modify the chemical structure of a promising candidate probe, with existing affinity
for amyloid plaques and NFTs to enhance its binding affinity and NIR-II fluorescence emission. In the second
approach, we will screen an existing chemical library of > 650 NIR fluorophores using chemical structure-activity
modeling and in vitro and in vivo characterization. To image our candidate NIR-II fluorophores in vivo, we will
build a custom multi-modal microscope combining NIR confocal and multiphoton microscopy and fully
characterize its performance with simulations and experimental validation. We will conduct longitudinal, in vivo
imaging studies in AD mice to validate our developed probes and instrumentation and demonstrate for the first
time non-invasive monitoring of AD pathology with microscopic resolution. The excellent scientific environment
and world-class resources provided by the Massachusetts General Hospital and Harvard Medical School, as
well as the internationally recognized leadership of the applicant's mentors, along with the expertise of the
proposed collaborators, will be key to the successful completion of the proposed research. This K01 award will
be instrumental for the applicant to strengthen his skillset with training in optical probe development and in vivo
imaging in AD mice and to take the next steps towards becoming an independent researcher.

Public health relevance
PROJECT NARRATIVE Alzheimer's disease (AD) is progressive neurodegenerative disorder characterized by the extracellular accumulation of amyloid β (Aβ) deposits and the formation of intracellular tau-containing neurofibrillary tangles in the brain. This proposal aims to develop the near-infrared optical probes and instrumentation that will enable, for the first time the non-invasive monitoring of the dynamics of these pathological protein aggregates in AD mouse models with cellular resolution. The developed tools and techniques will represent a significant advance in our ability to assess therapeutic strategies when conducting preclinical mouse studies in AD.